The biochemical mechanism and pharmacological inhibition of phosphatidylinositol phosphate kinases

Project Summary / Abstract
The objective of the proposed research is to elucidate the biochemical mechanisms underlying the exquisite
substrate binding and catalytic specificity of two phosphatidylinositol phosphate 5-kinases (PIP5K, PIKfyve).
The PIPK family of lipid kinases include PIP5K (type 1), PIP4K (type 2) and PIKfyve (type 3), and is primarily
responsible for converting phosphatidylinositol monophosphate lipids into PI(4,5)P2 and PI(3,5)P2. Despite
sequence homology, these kinases are highly selective in substrate binding [PIP5K binds PI(4)P, PIP4K binds
PI(5)P, and PIKfyve binds PI(3)P] and in catalytic activity [PIP5K and PIKfyve phosphorylate the C5 hydroxyl of
the lipid's inositol head group, whereas PIP4K phosphorylates the C4 hydroxyl]. We and others have
previously identified two structural elements within the kinase domain, the specificity loop and a conserved
PIP-binding motif, that contribute to substrate selectivity, but how these two elements cooperate to confer
kinase specificity remains undefined at the structural level. In aim 1, we plan crosslinking strategies to stabilize
the specificity loop to facilitate co-crystallization with lipid substrates. We also plan to generate and crystallize a
minimalistic catalytic core domain of PIKfyve. In aim 2, we propose genetic and chemical biological
experiments to examine the role of PIKfyve in the life cycle of SARS-CoV-2. Several large-scale drug
repurposing programs have identified apilimod, a PIKfyve inhibitor, as a top lead in suppressing SARS-CoV-2
replication in cell culture (a phase II clinical trial of apilimod in treating COVID-19 is ongoing at the Yale Center
for Clinical Investigation). This discovery, together with earlier observations that apilimod also reduces infection
by Ebola and Marburg viruses, has generated great interest in pharmacologically targeting PIKfyve. Drawing
on structural and biochemical knowledge about the lipid kinase family, as well as chemical tools previously
developed to target PIP4K, we have discovered a new class of potent PIKfyve inhibitors and plan to use them
together with apilimod to interrogate how PIKfyve inhibition disrupts SARS-CoV-2 infection. All previously
known PIKfyve inhibitors are structurally related to apilimod, and their binding mode to the lipid kinase is
unknown. The new inhibitor class is significant because it not only adds confidence to the proposed
involvement of PIKfyve in SARS-CoV-2 infection, but also has a known binding mode to PIPK, which should
facilitate future optimization by medicinal chemistry.

Public health relevance
Project Narrative The phosphatidylinositol phosphate 5-kinases are responsible for the synthesis of two functionally important phosphatidylinositol bisphosphates, PI(4,5)P2 and PI(3,5)P2. Biochemical and crystallographic experiments are planned in this application to study how these lipid kinases achieve substrate specificity and how pharmacological inhibition of PIKfyve could disrupt SARS-CoV-2 replication within infected cells.